Role of NOD2 in Acute Lung Injury Following Ischemic Kidney Injury

Abstract
Acute respiratory distress syndrome (ARDS) is characterized by pulmonary endothelial inflammation that leads
to alveolar edema and poor gas exchange. It has a high mortality, and effective treatment options to date are
limited. Acute kidney injury increases the mortality from ARDS and there is substantial evidence that kidney
injury can directly worsen the lung injury. The mechanisms underlying this kidney-lung interaction are not well
understood and could hold therapeutic potential. Following renal ischemia reperfusion injury (IRI), endogenous
stress molecules (DAMPs or damage associated molecular patterns) are released from dying renal tubular cells
and bind to pathogen recognition receptors (PRRs) on neighboring cells, initiating an inflammatory cascade that
worsens renal injury. In preliminary data we have already seen that renal derived DAMPs cause upregulation of
inflammatory cytokines and MAPK activation in uninjured renal tubular epithelial cells. Expanding this model to
kidney-lung cross talk, human pulmonary endothelial cells exposed to renal tubule-derived DAMPs were found
to upregulate inflammatory cytokines and specific PRRs. These preliminary data also revealed that NOD2, a
PRR known to play a key role in acute kidney injury, was disproportionately upregulated when compared to other
PRRs. Our lab has previously shown that NOD2 knockout protects mice from renal IRI, and preliminary data
suggest that inhibition of NOD2 via pharmacologic blockade decreases the inflammatory response of renal
tubular epithelial cells to renal derived DAMPs. The hypothesis of this proposal is that NOD2 plays a critical role
in lung injury following renal IRI by inducing proinflammatory responses in the pulmonary microendothelium,
contributing to ARDS. Given the importance of microvascular endothelial cells in the pathogenesis of ARDS, this
proposal focuses on the role of NOD2 on injurious responses in pulmonary microvascular endothelial cells after
renal IRI. I will focus on the canonical NOD2 signaling pathways in pulmonary microvascular endothelial cells in
response to renal derived DAMPs and also use an in vivo model of renal IRI to correlate NOD2 activation with
lung injury. This proposal will provide important new knowledge and skill sets needed to set the stage for the
development of my career as a physician-scientist. The work proposed in this application will be conducted in a
rich training environment at UC San Diego and the Scripps Research Institute with an exceptional
interdisciplinary mentoring team including leaders in the field of innate immunity, endothelial cell biology, and
ARDS.

Public health relevance
Project Narrative Acute lung injury in the intensive care unit has a high mortality and is worsened by acute kidney injury. The mechanisms behind the kidney-lung interaction are not well understood and have potential as therapeutic targets to improve patient outcomes. The proposed project studies how activation of the intracellular innate immune receptor NOD2 contributes to acute lung injury following acute kidney injury.